The Prognostic and Predictive Impact of Telomere Length in Fibrotic Interstitial Lung Disease

PROJECT SUMMARY/ABSTRACT
The interstitial lung diseases (ILD) are a group of incurable fibrotic and inflammatory disorders that confer
substantial mortality risk through progressive loss of lung function. The ILDs are categorized into discrete
diagnostic subtypes to inform clinical management. However, diagnostic categorization is imprecise and is
unable to reliably identify individual patients at high risk for rapid progression or poor survival. Leukocyte telomere
length is an emerging prognostic biomarker that consistently informs individual progression and mortality risk. In
addition, a recently discovered pharmacogenomic interaction between short leukocyte telomere length and
immunosuppressant medications suggests that leukocyte telomere length is also a predictive biomarker that can
aid in ILD treatment selection. This proposal seeks to leverage a multicenter cohort of >4000 ILD patients to
outline relevant information gained from clinical leukocyte telomere length measurement across the spectrum of
fibrotic ILDs. In Aim 1, we will quantify the age-adjusted leukocyte telomere length threshold that best informs
differential progression and mortality risk. Using these thresholds, we will then calculate performance
characteristics to provide clinicians with discriminatory power of leukocyte telomere length in forecasting
outcome risk to inform clinical decision making. In Aim 2, we will study treatment naïve fibrotic ILD patients to
quantify the effect of age-adjusted leukocyte telomere length on incident progression and near-term mortality
while accounting for ILD treatment effects. This aim will quantify the independent impact leukocyte telomere
length and treatment selection on ILD outcome risks. In Aim 3, we will create a risk prediction model anchored
on leukocyte telomere length that informs both near-term progression and mortality risk. We will then incorporate
subsequent treatment exposure to calculate the change in risk profile conferred by specific treatment selection.
Successful completion of the proposed aims will create a tractable predictive tool integrating a blood biopsy with
clinic-radiologic features that informs personalized ILD management without constraints of the current, imprecise
ILD diagnostic categorization. In addition, results from these studies will form the foundation for future
prospective cohort studies and stratified clinical trials to validate the ability of leukocyte telomere length to
function as a prognostic and predictive biomarker and usher in the era of precision medicine in fibrotic ILD.

Public health relevance
PROJECT NARRATIVE In this proposal, we will quantify the link between leukocyte telomere length and progression and mortality risk, irrespective of fibrotic ILD diagnostic subtype. We will determine the impact of treatment selection on telomere- mediated outcomes and develop a clinical tool to improve fibrotic ILD risk stratification and medication selection. These data will outline the prognostic and predictive impact of leukocyte telomere length across the spectrum of fibrotic ILD.